Differential regulation of mast cell-mediated allergic responses by IL-10

PROJECT SUMMARY
This project focuses on the mechanisms by which IL-10 differentially regulates and promotes
mast cell (MC) hyperplasia, heterogeneity, activation and cellular functions during the
development of IgE and non-IgE-mediated allergic responses to food antigens.
We have demonstrated a key role for the immunomodulatory cytokine IL-10 in driving MC
expansion, activation, and cytokine production during food allergy. IL-10-primed MCs exhibited
enhanced proliferation, IgE-mediated passive anaphylaxis, and the production of TH2-type
cytokines. This suggests a novel role for IL-10 in the homeostasis and function of MCs. However,
the mechanisms by which IL-10 promotes MC activation are not very clear and remain to be
determined. Furthermore, whether these proinflammatory effects of IL-10 on MCs extend to
specific MC lineages, are global in nature, or context-dependent also remain to be examined. This
project combines hypothesis testing and targeted mechanistic approaches to further probe the
mechanisms by which IL-10 regulates MC functions. These include understanding whether IL-10
differentially regulates MC responses to distinct antigenic stimuli, assessment of its effects on
heterogeneous MC subsets, and determination of whether its effects are controlled by the source
cell type. The long-term overall goals are to: 1) identify cell-intrinsic and extrinsic factors by
which IL-10 promotes or suppresses distinct MC populations and regulates their effector function
during type 2 inflammatory responses; and 2) examine the systemic and functional local tissue
consequences of regulation of MC expansion and activation by IL-10. Aim 1 will elucidate whether
IL-10 promotes IgE-mediated mucosal MC responses to physiological food antigens such as
peanut and egg allergen and examine its effects on non-IgE-mediated pathways of allergic
sensitization including IL-33-induced anaphylaxis. Whether the effects of IL-10 also extend to
connective tissue MCs will be assessed and the phenotypic and transcriptomic profiles of both
MC subsets will be mapped. Aim 2 will assess the contributions of cell-intrinsic and paracrine IL-
10 to MC hyperplasia and effector function. Aim 3 will identify the effects of source-dependent IL-
10 and determine whether TH2 or non-TH2-derived IL-10 can differentially regulate MC function.
Given the known pleiotropic pathologic and regulatory effects of IL-10 during various T and MC-
mediated immune responses including anti-parasitic responses and allergy, and considering its
status as a canonical immunoregulatory cytokine, it is important to further identify the mechanisms
underlying the proinflammatory effects of IL-10 and its ability to promote rather than suppress
MC-dependent responses. As such, these studies are not only relevant to the mission of NIAID
but may also serve to identify precision-based approaches for therapeutic interventions.

Public health relevance
NARRATIVE: Mast cells play a critical role in the induction of immune responses, promoting both IgE-dependent allergic responses such as food allergy and non-IgE-mediated inflammatory diseases such as rheumatoid arthritis. Our studies provide a unique opportunity to dissect the mechanisms by which IL-10 modulates mast cell function in the context of both IgE-mediated activation as well as IgE- independent signals such as IL-33 stimulation. These investigations will not only provide key mechanistic insight into the proinflammatory effects of IL-10 on activated mast cells, but also further enhance our understanding of how mast cells promote the development of allergic responses towards better therapeutic approaches.